Administrative Core

The Administrative Core D of this Program Project serves three functions: 1} To provide the Projects and Cores with administrative and secretarial support to carry out the scientific goals of the Program Project, its general administration, fiscal oversight, and communication among participants in the Program. 2) To provide a centralized structure for the coordination of research meetings, travel arrangements, journal clubs, work in progress presentations, seminars and retreats. 3) To provide support for overall scientific direction, to facilitate review by the internal and external advisory committees and the preparation of progress reports and renewal applications. The College of Medicine will not provide these services.